Regulation of Adipose Tissue Inflammation by Antigen Presenting Cells

DESCRIPTION (provided by applicant): Obesity threatens the health of children and adults in the U.S. due its strong association with diseases such as metabolic syndrome and Type 2 diabetes. The pro-inflammatory signals induced by obesity are recognized as a mechanism by which obesity causes morbidity and mortality from these diseases. Adipose tissue macrophages (ATMs) are important mediators of obesity-induced inflammation. They are activated in obese fat and dysregulate metabolism by interfering with normal fat cell function. We have made the key discovery that ATMs exist as distinct subtypes that are regulated differently depending on the state of obesity. Recently, studies have demonstrated that T cells also participate in adipose tissue inflammation and may partner with ATMs to cause inflammation in obese adipose tissue. A fundamental unanswered question is: what is the nature of the signals and cell-cell interactions that initiate the inflammatory changes in fat with obesity? This proposal will address this question by examining the hypothesis that ATMs function as antigen presenting cells to communicate with and activate inflammatory CD4+ T cells in fat. This hypothesis is based on our preliminary data demonstrating that ATMs can activate T cells in an antigen-dependent manner. Furthermore, we have identified two receptors found on ATMs that are required to generate the obesity-induced changes in T cells in fat. Our study will apply several technical and conceptual innovations to study the interaction between ATMs and T cells. We propose a model where, in the early stages of obesity, T cells are activated by obesity-induced signals in fat that are transmitted by the resident population of ATMs. With more severe obesity, inflammatory ATMs are recruited to fat and amplify T cell inflammation. We will test this model and reveal the mechanisms behind these events by using mouse models of obesity to address three specific aims. (1) To identify the mechanisms by which obesity alters the ability of ATMs to activate CD4+ T cells. (2) To understand the mechanisms by which MGL1, a receptor found only on resident ATMs, participates in the initiation of adipose tissue inflammation and T cell activation. (3) To assess how antigen presentation on recruited inflammatory ATMs contributes to the maintenance of adipose tissue inflammation. The impact of these inflammatory interactions will be related to the physiologic changes in glucose and lipid metabolism that are relevant to human health. Accomplishing these aims will provide a novel insight into how adipose tissue inflammation is initiated. Importantly, identification of the types of cell-cell communications that regulate inflammation in adipose tissue can identify novel points for intervention to uncouple obesity from its negative effects on health. PUBLIC HEALTH RELEVANCE: Inflammatory activation in obesity contributes to the development of insulin resistance and diabetes. This inflammation is largely generated by the activity of inflammatory cells found in fat tissue that change as fat mass increases. This proposal will investigate how two important inflammatory cells in fat, macrophages and T cells, communicate in adipose tissue. Results of this study could lead to novel therapies for type 2 diabetes that are directed towards blocking obesity-induced inflammation.

Public health relevance
Public Health Relevance Section Inflammatory activation in obesity contributes to the development of insulin resistance and diabetes. This inflammation is largely generated by the activity of inflammatory cells found in fat tissue that change as fat mass increases. This proposal will investigate how two important inflammatory cells in fat, macrophages and T cells, communicate in adipose tissue. Results of this study could lead to novel therapies for type 2 diabetes that are directed towards blocking obesity-induced inflammation.